Core A: Administrative

PROJECT SUMMARY/ABSTRACT
The Administrative (Admin) Core (Core A) is the coordinating hub of the Emory CFAR with responsibility for
scientific leadership, effective stewardship of resources, investment in innovative HIV research initiatives, and
support for the recruitment of Early-Stage Investigators. This is accomplished through five science cores and
two Scientific Working Groups. Core services are evaluated annually, and resources leveraged to ensure the
evolving needs of HIV researchers are met. The Admin Core continues funding developmental awards and
promoting training programs moving early-stage investigators to independent funding with a focus on women
and underrepresented minorities. We seek a revision to the Admin Core to include the nationally focused
CFAR Adelante Research Capacity Program (CFAR Adelante). The key tenets of CFAR Adelante are team
science, mentorship, and community engagement with a goal to build long-term community-academic
partnerships. Program participants benefit from multi-level and bidirectional mentorship relationships and
scientific mentorship—goals that perfectly align with those of the Emory CFAR. Through the end of this project
period, we propose to 1) provide funding for the currently awarded AMRP Cohort V Teams to complete their
two-year projects; 2) support one additional cohort of up to four Adelante Teams; and 3) recruit another cohort
of up to four Adelante Teams. The Emory CFAR is Co-Directed by three distinguished HIV investigators
providing complementary expertise across all major areas of HIV research at Emory. Dr. Carlos del Rio is
contact PI and Co-Director for Clinical Science, Dr. Colleen Kelley is MPI and Co-Director for
Prevention Science, and Dr. Ann Chahroudi is MPI and Co-Director for Basic Science. The Admin Core
will continue to provide scientific leadership, effective stewardship of resources, and extensive administrative
support to ensure the success of the Emory Adelante and its integration into the following aims:
Aim 1. Provide scientific leadership and coordinate activities that support CFAR Members as they advance
groundbreaking HIV research across the entire scientific spectrum of NIH-defined priority research areas to
end the epidemic for all and to promote health equity.
Aim 2. Allocate resources effectively and judiciously to support six Cores and two Scientific Working Groups,
providing cutting-edge tools and services to elevate multidisciplinary and translational HIV research.
Aim 3. Develop the next generation of outstanding and diverse HIV investigators through innovative
developmental grant programs, leadership development and mentoring, and promotion of inclusion and
diversity in all aspects of the Emory CFAR.
Aim 4. Utilize intentional communication and dissemination strategies to promote multidirectional stakeholder
engagement between HIV researchers and the communities we seek to serve.